MIDWEST PROGENITOR CELL CONSORTIUM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Objective: To convert human pluripotent stem and somatic cells into hematopoietic stem cells (HSCs) and self renewing cardiac progenitor cells. The Midwest Progenitor Cell Consortium is a collaboration between the UW-Madison and the University of Minnesota, which will serve as a research hub within the NHLBI's Progenitor Cell Biology Consortium. The goal is to develop new strategies to convert human pluripotent stem and somatic cells into hematopoietic stem cells (HSCs) and self renewing cardiac progenitor cells through identification of genetic program leading to formation of pre-HSCs and cardiac progenitors and activation of self-renewal program in lineage restricted cells. This project uses WNPRC Stem Cell Resources.